Integrative Multiomics to Probe Interactions of the Gut Microbiome with Malaria Pathogenesis and Antimalarial Pharmacokinetics in Humans

PROJECT SUMMARY/ABSTRACT
Malaria has exerted a selective pressure on the human genome over hundreds of millennia. Evidence suggests
that malaria may have also influenced the human microbiome. Animal and human studies previously showed
associations between the gut microbiome and malaria severity, the risk of infection, anti-Plasmodium immunity,
and antimalarial pharmacokinetics. Conversely, infection with Plasmodium has been shown to acutely alter the
gut microbiome, offering for example one explanation for the long-observed association between malaria and
non-typhoidal salmonellosis. We propose to investigate various clinical and parasitological relationships between
acute P. falciparum infection and the human gut microbiome in the context of a recently completed randomized
controlled trial (NCT04009343) and an existing observational cohort, leveraging recent advances in multiomics
technology and bioinformatics to pursue mechanistic questions about the malaria-microbiome nexus in a human
population.
The proposed research is structured according to 3 specific aims that leverage existing fecal specimens and
participant data from a recently-completed clinical trial of uncomplicated malaria and forthcoming samples from
a Johns Hopkins Malaria Research Institute-funded observational cohort of severe malaria. Aim 1 will deploy
metagenomics and metatranscriptomics to characterize the structure and functional potential of the intestinal
microbiome and interrogate its relationships to multiple clinical and parasitological outcomes. Aim 2 will leverage
existing plasma drug concentration data from a multidose pharmacokinetic design to assess the potential
impacts of the microbiome on orally-administered antimalarial drugs. In nonlinear mixed effects models of drug
pharmacokinetics, we will test interactions of the primary parameters with structural and derived functional
features of the intestinal microbiome. Microbial biochemical pathways of interest that emerge from Aim 1 and 2
results will be tested by integration of metabolomic data generated under Aim 3 with metagenomic and
metatranscriptomic data, identifying candidate biomarkers and targets for prognosis, prevention, and adjuvant
treatment for future study.
The proposed research will generate foundational evidence of clinically and pharmacologically relevant
malaria-microbiome interactions in a patient population. More broadly, this work will expand our understanding
of the role of the microbiome in disease pathogenesis and drug pharmacokinetics. The investigative team joins
malariology and clinical pharmacology expertise with molecular, epidemiological, and computational
microbiome-focused expertise to establish a 5-year research project that employs the most up-to-date
technology and methods in multiomics to an oft-understudied but globally significant disease. The results would
build significantly upon findings from preclinical studies of malaria and the microbiome, which have yet to be
translated conclusively to field studies.

Public health relevance
PROJECT NARRATIVE Malaria poses a public health threat in tropical and subtropical areas of the world where the disease may have influenced not only the human genome but the human microbiome over millennia of selective pressure. Understanding the relationship between malaria and the microbiome can provide new insight into the biological mechanisms that govern the complex interplay among human, parasite, and anti-malarial drugs. This project will leverage existing clinical trial samples and collect new samples from patients with malaria to characterize the relationships between the human gut microbiome and malaria disease progression, malaria-related alterations to the human microbiome, and gut microbial metabolism of antimalarial drugs using cutting-edge methods in genomics, transcriptomics, and metabolomics.